Health Communications (HC)

Patient-centered communication tailored to the specific needs of individuals, patients, and family members is
an essential part of high-quality cancer care. The Health Communications Shared Resource (HC-SR) enables
Rogel Cancer Center (Rogel) members to conduct state-of-the-science research using innovative
communication channels and technologies in wide-ranging settings across the continuum of cancer care. HCSR is comprised of an interdisciplinary team of behavioral and communication scientists, designers and
graphic artists, and technologists and programmers that work together to create user-centered interventions.
The aims of the HC- SR are to i) enable Rogel members to conduct state-of-the-science health
communications research across the continuum of cancer care; ii) apply health communication science to
advanced patient and family member engagement with cancer research and the practice of precision oncology;
iii) apply health communication science and strategies to engage community partners in advancing cancer
research and addressing differences in cancer-related health outcomes in our Rogel catchment area.